Role of deltaFosB in Neuronal and Cognitive Function

? DESCRIPTION (provided by applicant): Alzheimer's disease (AD) is a neurodegenerative disease that accounts for approximately 50-80% of dementia cases worldwide. The disease is characterized by progressive cognitive decline and severe memory loss. As current therapies for AD offer limited benefit if any, the need to better understand the mechanisms of cognitive decline in AD cannot be overstated. The key finding that AD is associated with seizures may provide valuable insight into these mechanisms. Recent evidence suggests that seizures in AD are not just incidental, but may play an active role in contributing to cognitive decline early in disease progression. Consistent with this, treatment of both AD patients and AD mouse models with antiepileptics improves cognitive function. Therefore, understanding how seizures contribute to cognitive decline may open an avenue to discover novel therapies that can mitigate cognitive deficits and improve quality of life for AD patients, as well as for patients wih other neurological disorders accompanied by seizures. As such, this proposal focuses on the molecular and cellular changes induced by seizures in the hippocampus, a brain region severely affected by AD. Preliminary studies utilizing transgenic mice that express the human amyloid precursor protein (APP) carrying disease-linked mutations revealed that these mice exhibited epileptic spike activity and seizures as early as two months of age, just prior to the onset of cognitive deficits and significantly earlier than amyloid plaque deposition. Furthermore, examination of hippocampi in these mice showed markedly increased expression of a transcription factor ΔFosB. This finding was particularly interesting considering that the increas in ΔFosB expression corresponded with both epileptic activity in the brain as well as cognitive impairment. Previous studies of ΔFosB in other brain regions demonstrated that this transcription factor has an unusually long half-life (on the order of weeks) and interacts with HDACs. As such, ΔFosB may play an important role in long-term epigenetic gene regulation. Notably, our preliminary investigation of ΔFosB in the hippocampus revealed two important gene targets: cFos and calbindin-D28k. Since these genes play important functions in synaptic plasticity as well as cell survival, their regulation by ΔFosB supports the hypothesis that ΔFosB contributes to both neuroprotection and synaptic dysfunction during states of chronic neuronal hyperexcitation. Therefore, the goals of this proposal are to elucidate the functions of ΔFosB in AD and other seizure-related disorders. The Aims of this proposal are to 1) evaluate whether expression of ΔFosB is sufficient to drive gene expression changes and cognitive dysfunction in vivo and 2) investigate the mechanisms by which ΔFosB epigenetically regulates target genes, and the role that ΔFosB plays in neuroprotection in vitro. Results from these studies will pave the way for the development of much-needed novel therapies to improve cognitive function in AD and other seizure-related disorders.

Public health relevance
PUBLIC HEALTH RELEVANCE: Alzheimer's disease (AD) is a neurodegenerative disease associated with progressive cognitive decline and an increased incidence of seizures. Recent studies suggest that seizures actively contribute to cognitive decline, but how they do so is unclear. Understanding the molecular mechanisms by which seizures affect cognition and brain function will pave the way for novel therapeutics for AD as well as other neurological disorders accompanied by seizures.